Fostering Institutional Resources for Science Transformation: The FLORIDA-FIRST Health-Science Brigade

PROJECT SUMMARY Several factors contribute to FSU’s potential to create cultural transformation through an innovative approach to hiring, supporting, and retaining URM faculty. First, our College of Medicine was founded in 2000 to train physicians to serve rural communities throughout the panhandle region and the State of Florida. Given the racial and ethnic diversity of these areas, we have created a rich community-based network upon which to integrate academic health-science efforts across our Colleges of Medicine, Nursing, and Arts and Sciences. Second, in 2013, the Florida Board of Governors designated FSU as one of two preeminent universities which triggered an increased state commitment of $75 million from 2013 to 2018. FSU leadership invested these funds to advance health-science research, including the creation of the Equity Research Corner (a consortium of eight centers and institutes) with the mission to address equity issues related to health, social, and educational barriers at the levels of individuals, families, and communities . Third, FSU has created resources to support faculty conducting clinical translational research through our NIH-funded Clinical Translational Science Award subaward. Fourth, FSU has committed in its Strategic Plan (Goal III) to institutional change to foster diversity, inclusion, and equity at all levels and through the President’s Task Force of Anti-Racism, Equity, and Inclusion. We will leverage these resources to test the robustness of The FLORIDA-FIRST BRIGADE for promoting a self-reinforcing community of scientists committed to inclusive excellence. In response to RFA-RM-20-022, we propose three specific aims for the Overall Core: Aim 1. Achieve significant and sustainable cultural change at FSU to ensure inclusive excellence and diversity at the macro (institutional), meso (hiring unit/Center/department), and micro (faculty) levels. Aim 2. Recruit, hire, and retain 6 new URM faculty within the clusters of chronic disease prevention and management or mental health to form The FIRST Cohort as a replicable model for promoting diversity, equity, and inclusive excellence in health-science research at FSU. Aim 3. Develop and implement a systems-levels approach (macro, meso, micro) to establish individual research and career development plans and mentorship plans for each member of The FIRST Cohort. By recalibrating the standard institutional practices for URM faculty recruitment, development, and retention, The FLORIDA-FIRST BRIGADE has the potential to promote diversity and inclusive excellence1 for The FIRST Cohort and serve as an innovative model for the next generation of FSU health-science faculty.

Public health relevance
PROJECT NARRATIVE FSU aims to develop, implement, and evaluate a program, Fostering Institutional Resources for Science Transformation: The FLORIDA-FIRST Health-Science Brigade (aka The FLORIDA-FIRST Brigade), to transform culture at FSU to generate a self-sustaining scientific community dedicated to diversity, equity, and inclusive excellence. We propose leveraging institutional resources to recruit a FIRST Cohort of 6 early-career, URM biomedical researchers who demonstrate a commitment to diversity and inclusive excellence and who contribute to clusters of research excellence in chronic disease prevention and management (Cluster 1) or mental health (Cluster 2) and to implement a systems-level approach and generate evidence of its effectiveness for supporting individual faculty research and career development (micro), within their cohort and collaborative networks (meso), that can be replicated through sustainable changes to university culture (macro).